The University of Rochester Clinical and Translational Science Award Hub

Contact PD/PI: Zand, Martin S
CORE O: OVERALL – PROJECT SUMMARY/ABSTRACT
The Clinical and Translational Science Institute (UR CTSI) is the research engine of the University of Rochester
Medical Center. The UR CTSI has catalyzed research throughout the University, building a robust translational
research ecosystem. During the next five years, the UR CTSI will focus on “translational research without walls,”
moving beyond the physical and virtual confines of institutions. We will accelerate integration of translational
research with the Learning Health System. We will expand our innovative approaches to dissemination and
implementation (D&I) research including: a new and dedicated D&I KL2 scholar position, a Health-Equity
Focused Dissemination and Implementation Optional Function; and a collaborative pilot program focused
specifically on D&I projects within the Learning Health System. We will develop and disseminate novel
educational materials and methods. We will create a translational research data ecosystem that seamlessly
integrates data across the translational spectrum by linking our research and clinical data warehouses. We
will implement the ACT/SHRINE cohort discovery software and make extensive use of Center for Data to Health
(CD2H) tools, ontologies and working groups. We will expand education efforts across our pilot programs to
achieve translational research data and analytic excellence. We will enhance translational research
collaborations at the local and national levels across the spectrum of stakeholders. We will continue our
extensive participation with the CTSA Coordinating Centers. We will extend our successful program in
community-based participatory research, facilitating multidisciplinary team formation with community members.
We will expand our local and national collaborations. We will educate the next generation of translational
science workforce leaders, expanding our approaches to ensure competence in the collaborative, technical,
and regulatory skills necessary to accelerate the translation of high impact research to clinical applications. We
will develop and disseminate novel educational materials, investigator support, and methods. We will catalyze
the development, implementation and dissemination of methods and processes that advance
translational research locally and nationally across the CTSA Consortium through methods to advance
remote data and sample collection; speeding basic and early stage research with regulatory support and industry
sponsorship; and programs for rapid trial evaluation, negotiation, and approval. We will enhance our Participant
and Clinical Interactions Function to accommodate teleresearch visits and remote data and sample capture
methods. We will employ our existing strengths to implement and manage multi-site research studies.
Page 172
Project Summary/Abstract
Contact PD/PI: Zand, Martin S
CORE O. OVERALL –

Public health relevance
PROJECT NARRATIVE The five-year focus of the University of Rochester Clinical and Translational Science Institute is on “translational research without walls,” moving beyond the physical and virtual confines of institutions, by accelerating integration of translational research with the Learning Health System, expanding innovative approaches to dissemination and implementation and creating a translational research data ecosystem that seamlessly integrates data across the translational spectrum, linking our research and clinical data warehouses and expanding education efforts across our pilot programs to achieve translational research data and analytic excellence. We will enhance translational research collaborations at the local and national levels across the spectrum of stakeholders, extending community-based participatory research, facilitating multidisciplinary team formation and expanding our local and national collaborations. We will educate the next generation of translational science workforce leaders, expanding our approaches to ensure competence in the collaborative, technical, and regulatory skills necessary to accelerate the translation of high impact research to clinical applications, and we will catalyze the development, implementation and dissemination of methods and processes that advance translational research locally and nationally across the CTSA Consortium. Page 173 Project Narrative